A metabolic decision point in the progression of lymphoid malignancies

Despite recent therapeutic advances, curing lymphoid malignancies such as non-Hodgkin lymphoma and
lymphoid leukemia remains a clinical challenge. While critical for prognosis, the mechanisms regulating
malignant lymphocyte trafficking, migration, and solid organ infiltration are incompletely understood. Metabolic
flexibility plays a critical role during cancer progression aligning metabolic requirements of cancer cells with
specific tissue environments. In lymphoid cancers, however, little is known about the impact of metabolic
programming on cell migration and disease progression. Our preliminary studies demonstrate that malignant
lymphocyte migration and solid organ infiltration are tightly connected to cellular metabolic preferences. We
discovered that T- and B-lymphoid cancer cell migration and organ infiltration in xenograft models is
determined by mitochondrial reactive oxygen species (mROS) through analysis of mROSlow and mROShigh
states. This innovative strategy permits us to isolate cells with different migratory potentials to dissect fuel
preferences of the “enhanced migratory potential”-mROShigh (EMP-mROShigh) state. We identified glucose as
an essential fuel driving migration through activation of mROS/HIF-1a signaling. Initial 13C-glucose tracing
studies showed reprogrammed glucose metabolism in migrating cells. Reduced pyruvate oxidation in the TCA
cycle and enhanced lactate generation promoted migration through HIF-1a signaling. These results support
our hypothesis that the branch point in pyruvate flux is a critical “metabolic decision point” controlling malignant
lymphocyte migration and organ infiltration. We predict that dynamic shifts in pyruvate flux between
mitochondrial oxidation and conversion into lactate control migratory and infiltrative potential through
transcriptional regulation of mROS/HIF-1a-dependent cellular migration programs. The following specific aims
will test this hypothesis:
Aim 1. Establish the role of pyruvate flux as a decision point to control malignant lymphocyte
migration and infiltration. We will test the hypothesis that a shift in pyruvate metabolism between TCA cycle
oxidation and reduction to lactate represents a critical checkpoint of malignant lymphocyte migration and solid
organ infiltration through modulation of mROS/HIF-1a signaling.
Aim 2. Identify the molecular mechanisms for control of migratory behavior by the metabolic decision
point. This aim will test the hypothesis that pyruvate flux as a metabolic decision point controls migration
through transcriptional regulation of mROS/HIF1a-dependent cellular migration programs. We will perform
RNAseq analyses of CLL cells followed by functional analyses to identify genes translating metabolic
reprogramming into migration potential.
Aim 3: Dissect fuel preferences and metabolic reprogramming of enhanced migratory cancer cells
through in vivo metabolic tracing in CLL patients. We will test the hypothesis that the EMP-mROShigh cells
in CLL patients in vivo show reprogrammed glucose and TCA cycle metabolism analogous to the in vitro
phenotype. Patients will be infused with 13C-labeled nutrients to determine pyruvate flux and TCA cycle fueling
in “enhanced migratory potential” CLL cells in their in vivo habitat critical to help define therapeutic strategies
targeting the EMP-mROShigh phenotype in patients.
Elucidating the metabolic underpinnings of malignant lymphocyte migration and solid organ infiltration will
provide important insight into disease biology and uncover novel treatment strategies for lymphoid
malignancies such as CLL which are highly relevant to the Veteran population due to their link to Agent Orange
and other herbicide exposures during military service.

Public health relevance
Non-Hodgkin’s Lymphoma (NHL) and chronic lymphocytic leukemia (CLL) are linked to Agent Orange and other herbicide exposure during military service increasing the risk in the US Veteran population. While new therapies have improved survival rates of some lymphomas, advanced disease stages often remain fatal. Malignant lymphocyte trafficking, migration, and solid organ infiltration are critical drivers of disease progression and fatality. Metabolic flexibility plays a key role during cancer progression aligning metabolic requirements of cancer cells with specific tissue environments and, thus, might represent critical therapeutic target for improved treatment strategies. Identification of the metabolic reprogramming and fuel needs driving migration and organ infiltration potential in malignant lymphocytes will provide important insight into disease biology and uncover novel treatment strategies for lymphoid cancers affecting military Veterans exposed to chemical hazards.